Smoking-related Differences in Baroreflex Sensitivity and Fear Inhibition in Adults Who Do and Do Not Smoke Cigarettes

PROJECT SUMMARY/ABSTRACT
Evidence that anxious smokers experience lower cessation success and account for a greater proportion of
tobacco-related disease and disability underscores the need to identify common factors that underlie this
comorbidity and improve outcomes in this vulnerable population. Research initiatives addressing cigarette use
and anxiety have largely overlooked physiological mechanisms that facilitate body-brain communication,
despite their promise as malleable intervention targets. To address this gap, study designs are needed that
characterize (1) the effects of cigarette use on physiological processes that support body-brain communication
and (2) how these impairments confer anxiety risk in human models.
This application proposes that the baroreflex, a well-delineated feedback loop through which body-brain
communication occurs, is likely to be impaired in cigarette smokers and, as a result, may undermine core
learning processes that confer anxiety risk. The proposed study will involve a single in-person laboratory visit
during which 66 participants (n=33 smokers; n=33 non-smokers) will complete a fear conditioning paradigm
while baroreflex function assessed. Dependent variables include: (1) baroreflex function indexed via
electrocardiograph and blood pressure data and (2) fear inhibition indexed via skin conductance response
during the paradigm’s extinction training phase. Analysis of variance, linear regression, and mediation
modeling will be used to examine group differences in baroreflex function between smokers and non-smokers
(Aim 1), the relationship between baroreflex function and fear inhibition (Aim 2), and the direct and indirect
effects of smoking status on fear inhibition through the baroreflex (Aim 3), respectively. Findings will refine
knowledge of physiological processes implicated in anxiety, smoking, and their high comorbidity.
The applicant is applying for an F31 award to receive high caliber training in the design and implementation of
mechanism-focused addiction research (Goal 1), translational models of anxiety pathology (Goal 2),
psychophysiological interpretation and analysis (Goal 3), and professional development (Goal 4). The research
and training plan will lay the foundation for the applicant’s future line of research to examine how substance-
related impairments in physiological function promote anxiety risk and maintain substance use behavior.
Receiving an F31 fellowship will relieve the applicant from her time-intensive teaching assistant position to
effectively to conduct research and establish a strong interdisciplinary network in the addiction science field.

Public health relevance
PROJECT NARRATIVE Anxious smokers account for a greater proportion of tobacco-related disease, underscoring the need to identify common mechanisms of anxiety-smoking risk. This application proposes four training goals and three research aims to launch a unique line of research that integrates best-practices in mechanism-focused addiction research, translational learning models of anxiety pathology, and psychophysiological data collection and analysis. The goal is to refine knowledge of physiological processes that underlie anxiety pathology, maintain smoking behavior, and promote their high comorbidity.